Feasibility and acceptability of biofeedback-based virtual reality for postoperative pain management in children and adolescents

PROJECT SUMMARY
Mind-body therapies, like biofeedback (BF), are effective treatments to decrease pain in children and adults.
While decades of literature support the use of BF to decrease pain, BF is not currently available for use in the
postoperative period as it is a resource-rich intervention. With the help of novel technologic innovations, like
virtual reality (VR), BF can be delivered in an engaging, less resource-intensive manner, resulting in a more
accessible therapy that can be applied in broader clinical settings. VR has also demonstrated efficacy to
decrease pain, but transient reductions in pain due to the redirection of attention are insufficient to treat
prolonged acute pain experiences. FOREVR VR (Functional Outcome Response to Engaging VR) is a first-of-
its-kind, VR-based BF intervention and delivery system. Combining VR and BF (VR-BF) synergizes the
immersion and entertainment of VR with the physiological modifications of BF to enhance and sustain each
modality’s therapeutic effects. VR-BF is an engaging and motivating therapy that children can perform
independently and that has shown efficacy in treating several disorders. Despite early evidence of efficacy,
VR-BF is a new therapy and has not yet been employed in perioperative care, thus no optimal duration and
frequency or defined treatment protocols for preoperative training and postoperative application of VR-BF exist.
This study marks the first to assess the implementation and use of VR-BF in the perioperative setting and
seeks to establish measurable milestones that have not been addressed in prior studies. The goal of this two-
phase study is to understand how to implement a novel VR-BF therapy for postoperative pain management in
children. Before conducting an efficacy trial of VR-BF versus active control, it is imperative to assess factors
that will impact the VR-BF intervention and, consequently, the efficacy of VR-BF to reduce pain and opioid use.
Our central hypothesis is that the use of VR-BF in pediatric patients undergoing surgery resulting in moderate
to severe pain will be feasible and acceptable, and that findings from this pilot trial will inform design of a large-
scale efficacy trial of VR-BF in this patient population. Specific aims: (1) Refine a treatment protocol for
preoperative education and training and postoperative application of VR-BF using FOREVR VR in children and
adolescents undergoing surgery; and (2) Conduct a pilot randomized controlled trial to assess the feasibility
and acceptability of perioperative use of VR-BF using FOREVR VR in children and adolescents undergoing
surgery. The multidisciplinary research team, a unique collaboration of an anesthesiologist, pain experts,
clinical psychologists, a biostatistician, and a clinical trial design expert; are ideally suited to accomplish these
research goals. Data from this R34 will inform design of a large-scale, randomized, clinical efficacy trial using
VR-BF to assess pain and opioid reduction in children and adolescents with acute postoperative pain. It will
provide insight on preoperative education and training and postoperative application of VR-BF, in efforts to
improve postoperative analgesia, reduce opioid and analgesic use, and assist in pain and stress management.

Public health relevance
PROJECT NARRATIVE The innovative techniques employed in this two-phased approach to the integration of a novel biofeedback- based virtual reality (VR-BF) intervention in the management of acute pain in children and adolescents undergoing surgery anticipated to cause moderate to severe pain are ultimately expected to increase our understanding of pediatric pain. The proposed research is relevant to NIH’s Federal Pain Research Strategy to find more effective, novel, nonpharmacologic approaches for pain management given the risks of tolerance, dependence, and addiction associated with opioids and this research is especially important for disparate populations (e.g., children) given the particular vulnerability of this population to the adverse effects of opioids. If the long-term aims of this project are achieved, this innovative delivery of effective mind-body therapy could change routine clinical practice in the pre- and postsurgical care areas and widespread implementation of VR- BF has the potential to improve postoperative analgesia, reduce opioid and other analgesic medication consumption, and assist in pain and stress management in a variety of patient populations.